Trans Spinal Delivery of a Targeted Nanoformulation of Curcuminoids to Treat AD

Technical Abstract
Neurodegenerative disorders affect over 40 million people worldwide and most, if not all, are mediated by
inflammation. Even though several drugs are approved by the FDA for treating neurological disorders such as
Alzheimer’s disease (AD), their efficacy as AD therapeutics has not been realized as extremely low levels of the
drug reach the brain. The goal of this Phase I project is to develop an effective targeted delivery system for the
bioactive curcuminoids, curcumin (CUR) and bisdemethoxycurcumin (BDMC), to mitigate AD and potentially other
neuroinflammatory diseases. We will apply our extensive experience in exosomes, drug delivery, plant
therapeutics and inflammatory responses for efficient, targeted delivery of bioactive curcuminoids to the
microenvironment of the brain where progressive increase in inflammation, amyloid plaque formation and
neurofibrillary tangles ultimately leads to manifestation of AD. We hypothesize that the combined administration
of CUR and BDMC will be highly effective at ameliorating neuroinflammation and aberrant AD-related gene
expression returning these biomarkers to pre-disease levels due to synergistic action via different mechanisms.
We also hypothesize that folic acid (FA)-functionalized exosomal formulations administered using a novel topical,
trans-spinal (t.s.) route will provide enhanced targeting to AD-related regions of the brain, including the cortex and
hippocampus. Exosomes cross the BBB efficiently and areas of the brain associated with AD have high levels of
folate receptors (FRs). Thus, t.s.-administered FA-ExoCUR/BDMC will deliver higher payload to the brain vs.
conventional routes. Our hypotheses are supported by 1) effective drug loading of curcuminoids onto bovine
colostrum exosomes, 2) higher levels (~5-fold brain) of curcuminoids in rodent tissues after oral treatment with
Exo-curcuminoids than free curcuminoids, 3) FA-exosomes can increase drug delivery to the brain which contains
high expression of FR4) reduced NFκB accumulation and decreased abundance of phosphorylated Tau (pTau)
and amyloid precursor protein (APP) expression in brain lysates of mice treated orally with ExoCUR/BDMC in
concurrence with increased expression of brain-derived neurotrophic factors (BDNF) comparable to levels in age-
matched untreated WT mice while free CUR/BDMC was ineffective, and 5) higher brain accumulation of exosomes
in mice treated via t.s. route vs. the traditional i.v. route. Investigators experienced in exosomes, drug delivery,
plant bioactives and animal models, leveraging extensive experience of Dr. Robert Friedland in AD research, will
pursue the following specific aims: Aim 1. Optimize ExoCUR/BDMC formulations and determine biodistribution
and toxicity in WT mice. Aim 2. Determine efficacy of FA-functionalized ExoCUR/BDMC formulations in AD mice.
This project will provide proof-of-principle for the effectiveness of t.s.-delivered FA-ExoCUR/BDMC on the
modulation of key molecular targets and cognitive function behavioral tests with AD progression. In Phase II, we
will conduct dose-finding and longer-term early and late intervention studies using multiple rodent AD models,
immunotoxicity, etc. The t.s.-brain delivery could ultimately lead to the development of t.s. patches for AD.

Public health relevance
Narrative (Public Health Relevance Statement) In the proposed project, we will use a novel nano formulation of curcuminoids to mitigate neuroinflammation and attenuate neurological diseases with emphasis on Alzheimer’s disease (AD). In our approach, curcuminoids, known for their potent anti-inflammatory activity and activities inhibiting early brain markers of AD including neurofibrillary tangles and amyloid plaque formation, will be sequestered in exosomes (natural nanoparticles), isolated from standardized bovine colostrum powder, to increase bioavailability. The exosomes will be decorated with folic acid whose receptors are expressed in high levels in the brain, to target the brain sub tissues such as cortex and hippocampus, and the formulation is delivered by a novel trans-spinal (t.s.) topical route for efficient brain delivery and the efficacy assessed using transgenic mouse model of AD.